Ex-vivo bioengineered technology to unravel dysfunction due to non-alcoholic steatohepatitis (NASH)

SUMMARY
Non-alcoholic fatty liver disease (NAFLD) is the most common cause of abnormal liver function tests in the US
and its progressive form, termed non-alcoholic steatohepatitis (NASH), will soon be the leading indication for
liver transplantation. There are currently no effective medications to treat NASH, no biomarkers to determine
disease progression or risk of post-transplant recurrence and no effective platforms for high-throughput drug
screening. Although NASH is related to obesity and diabetes, the pathogenic factors that cause disease
progression to NASH/Cirrhosis are poorly understood. Compared to an invasive liver biopsy, peripheral blood
mononuclear cells (PBMCs) can be easily obtained from patients with NASH and end-stage NASH/Cirrhosis
patients requiring liver transplantation and re-programmed into induced pluripotent stem cells (iPSCs). These
iPSCs may then be differentiated into iPSC-hepatocytes, which are human liver-like cells that can be cultured in
ex vivo bioengineered systems tailored to normal and cirrhotic liver stiffness, enabling an investigation that is
independent of the compounding metabolic and environmental factors that complicate analysis within human or
animal systems. In this proposal, we will utilize an iPSC-hepatocyte platform to determine the effects of
extracellular matrix (ECM) stiffness and unfolded protein response (UPR) cell signaling on hepatic lipid
metabolism. We will initially unwind the impact and interplay between matrix stiffness and patient-specific
propensity for NASH in patient-derived iPSCs and analyze the impact on lipid metabolism and lipidomics (Aim
1). ER stress and the unfolded protein response (UPR) has been shown to be important in the pathogenesis of
NASH. Thus, we will use iPSC-hepatocytes to develop a platform for determining the interaction between UPR
signaling and lipid metabolism relevant to NASH (Aim 2). iPSC-hepatocytes will be treated with ER stress
reducing compounds including the chemical chaperone tauroursodeoxycholic acid (TUDC) or FXR/bile acid
agonists, and the effects on cell differentiation, gene expression and lipid metabolism will investigated. Finally,
iPSC-hepatocytes will be used to study the cell signaling and pathogenic mechanisms of NASH in iPSCs from
patients with rapidly progressive NASH/Cirrhosis that require liver transplantation. We will develop an iPSC-
hepatocyte platform identifying matrix and UPR factors responsible for NASH using iPSC-hepatocytes from
NASH/Cirrhosis patients listed for liver transplantation (Aim 3). This MPI proposal leverages the collaboration
between three PIs at two institutions with extensive experience investigating 1) iPSCs, bioengineering matrices,
ECM biology, and transplant surgery, 2) hepatic lipid metabolism, cell signaling and transplant hepatology, and
3) lipidomics and metabolomics. The development and optimization of these iPSC-hepatocyte platforms will have
important implications for determining the pathophysiology of NASH, developing biomarkers to determine risk
for NASH progression and for use in drug development and personalized drug screening.

Public health relevance
NARRATIVE Approximately 15 million people in the United States are at risk for developing cirrhosis, liver failure, hepatocellular carcinoma and death due to non-alcoholic steatohepatitis (NASH), while there are less than 10,000 liver transplants performed annually in the United States. We are developing a novel stem cell and bioengineering-based platform where we will investigate two key factors in NASH, the effects of matrix stiffness and cell stress from unfolded proteins on induced pluripotent stem cell-hepatocytes (iPSC-hepatocytes). We will then make iPSC-hepatocytes from NASH patients listed for liver transplantation and controls to help develop platforms to study the causes of severe, progressive NASH and enable the development of biomarkers for NASH.